Homeobox protein Hhex in early T cell development

Project Summary
The proline-rich homeobox protein Hhex is important in hematopoiesis, in embryonic development, and in
cancer. A critical regulator of early embryonic hematopoiesis and other embryonic tissues, it is also known to
be required for hematopoietic stem cells to maintain the ability to give rise to T and B cell progeny. It is
intimately involved in several aspects of B cell development, and it is crucial for establishment of memory B
cells. However, how it enables stem cells to produce T cells has remained unclear and paradoxical. Normally,
Hhex is silenced during T cell lineage commitment and remains off in most mature T cells, sharply
distinguishing T cells from nearly all other hematopoietic cell types. Yet not only is Hhex needed to support T
lineage potential, but also forced expression of Hhex in T lineage cells can promote increased thymocyte self-
renewal. Is its role positive or negative, or both sequentially?
We propose that in fact Hhex roles can be reconciled as results of the need of early T-cell precursors to pass
through a “phase 1” progenitor-like regulatory state en route to a “phase 2” T-lineage-definitive regulatory state,
even though these states are mutually antagonistic. Our recent results show that Hhex at natural endogenous
levels is a potent regulator of T lineage differentiation speed, and suggest that it may initially delay the onset of
commitment by repressing a key T-lineage commitment regulator, Bcl11b. The role of Hhex in Bcl11b
regulation could provide much-needed insight into a control mechanism for large-scale epigenetic
transformation in development. Unexpectedly, our preliminary evidence also suggests that Hhex positively
regulates other factors expressed in the precommitment stage. This proposal thus grows from new data from
our group and exploits newly enhanced experimental systems that enable us to interrogate the functions of
transcription factors like Hhex, targeting specific stages from prethymic hematopoietic progenitors through T-
lineage commitment. This will empower us to reveal the specific target genes and mechanisms that Hhex uses
to control them when it is operating properly in T-cell precursors.
This will be undertaken through the following aims:
1. Determine the target genes in early T lineage cells affected by acute loss of Hhex: separate analyses
for cells pre and post contact with T-inductive Notch signaling microenvironment
2. Quantify the impact of Hhex on cell population survival and proliferation before and after contact with
Notch signaling and lineage commitment
3. Define Hhex functional targeting sites based on binding of epitope-tagged Hhex, and on ATAC
accessibility, H3K27 trimethylation, and TLE corepressor recruitment changes in early T lineage cells
under acute Hhex perturbation. Identify Hhex impact on chromatin of the Bcl11b gene

Public health relevance
Project Narrative To supply the body’s immune system, blood precursor cells need to balance the right amount of cell proliferation against the strict “education” process that converts them into T cells, for a mistake either way can lead to leukemia or immune deficiency. One powerful regulator called Hhex is noted for its involvement in leukemia in rare cases, but it also plays a crucial normal role in starting the T-cell production process. This project will shed new light on the nature of that normal role for Hhex and how it is distinguished from the deviant functions that lead to leukemia.